Rapid and Ultra-Pure mRNA Production with Next-Generation RNA Polymerases

PROJECT SUMMARY
Cisterna Biologics is addressing critical challenges in mRNA purification for therapeutic applications by
developing a novel production and purification process. This Phase I SBIR aims to generate ultra-pure mRNA,
essential for high-dosage and frequent administration in treatments ranging from enzyme replacement to cancer
immunotherapy. Traditional in vitro transcription (IVT) methods using T7 RNA polymerase produce significant
byproducts that can trigger adverse immune responses. In collaboration with the University of Texas-Austin,
Cisterna's approach involves the development of cold-adapted (psychrophilic) RNA polymerases (RNAPs),
which maintain high activity at low temperatures and reduce byproduct formation. Additionally, Cisterna's
proprietary SPEcific Capture and Cleavage (SPECC) purification technology intends to eliminate contaminants
completely. The Phase I SBIR project will demonstrate the capability of this technology to synthesize
contaminant-free mRNA, improving safety and efficacy for therapeutic use. Initial aims include optimizing
psychrophilic RNAPs and synthetic promoters to minimize contaminants significantly, with the ultimate goal of
replacing current gold-standard purification methods. The successful completion of this phase will pave the way
for Phase II, focusing on scaling up manufacturing and validating the platform in clinical settings. As the mRNA
therapeutics market is projected to grow substantially, Cisterna plans to establish itself as a leader in high-quality
mRNA production, leveraging its technologies and potential partnerships with biotech and pharmaceutical
companies.

Public health relevance
PROJECT NARRATIVE mRNA therapeutics hold great promise but face challenges from production impurities. Cisterna Biologics is addressing this by developing a novel production process employing cold-adapted RNA polymerases that significantly reduces impurities, enhancing mRNA safety and efficacy. Our goal is to set new industry standards for mRNA purity and advance the development of safer, more effective mRNA therapeutics.